Differential impacts of water insecurity on diet and body composition throughout the life course

PROJECT SUMMARY/ABSTRACT
Unreliable access to safe and sufficient water for all household uses (i.e., water insecurity) is a common but
understudied public health issue. Although water is itself a critical nutrient that is essential for agricultural
production, food preparation, and hygienic practices that reduce exposure to enteric pathogens, few studies
have examined the role of water insecurity in nutrition; most consider water quality only. A more holistic
conceptualization of water insecurity could reveal important pathways by which water accessibility, reliability,
and adequacy impact diet and health.
Water insecurity presents substantial barriers to cooking nutrient-dense foods, which often require
considerable water to be made palatable and safe for consumption. Qualitative studies have reported that water
insecurity limits breastfeeding duration and undermines the ability of caregivers to prepare preferred
complementary foods. Individuals experiencing water insecurity are also more likely to substitute water with
sugar-sweetened beverages, plausibly contributing to weight gain and increased risk of overweight and obesity.
The proposed project seeks to expand upon this formative work by examining the extent to which differential
exposure to water insecurity impacts diet quality and body composition throughout the life course.
A mixed-methods approach is required to comprehensively understand how water insecurity manifests at the
household level and subsequently impacts nutritional well-being. The proposed project will therefore use
qualitative data to complement quantitative data from 2 existing cohort studies that comprehensively measured
water insecurity and diet among infants, children, adolescents, and adults on San Cristóbal Island, Ecuador and
in Cebu, Philippines. Specifically, the project aims to qualitatively describe how issues with water availability,
accessibility, and use impact food production, purchase, and preparation (Aim 1). Multi-level modeling will be
used to assess whether household water insecurity undermines child diet quality (Aim 2) and longitudinal
structural equation modeling will be applied to evaluate how changes in household water insecurity throughout
early development impact adiposity (Aim 3).
The project will address a recognized knowledge gap within the field by using advanced statistical procedures
to model water insecurity as a multidimensional, time-varying exposure. Findings from this work have the
potential to reveal new targets for addressing the growing burden of malnutrition. Additionally, the proposed
rigorous curriculum in nutrition and epidemiology, as well as mentorship from thought leaders in the water and
nutrition sectors, will prepare the applicant for an academic career in global nutrition.

Public health relevance
PROJECT NARRATIVE Water creates an enabling environment for good nutrition but the ways by which water insecurity negatively impacts diet and health are not known. This proposed project uses qualitative and quantitative data from 2 islands with substantial water issues to understand if and how water insecurity, an increasingly common public health issue, contributes to poor diet quality and adverse changes in body composition. Findings from this project have the potential to identify upstream determinants of nutrition that can be targeted to address growing global malnutrition.